Recruiting and Retaining Underrepresented Students

Summary/Abstract Having improved the recruitment and retention rates of underrepresented (UR) students in the graduate program at the University of Texas Health Science Center San Antonio (UTHSCSA), we now shift our we now focus our attention on the development of novel and cutting edge practices and processes that will produce UR students that are not only highly competitive, but are leaders, in the biomedical workforce. Here we propose a series of systematic interventions designed to sharpen critical thinking skills and develop grant and manuscript writing as well as presentation skills. Successful integration of these strategies will prepare IMSD scholars for the most competitive positions in the biomedical workforce.

Public health relevance
This proposal seeks to enhance the training of underrepresented minority student pursuing their doctoral degrees in biomedical research. These students will potentially interact with the corresponding minority communities to address major issues related to health care. For example, we anticipate training Hispanic students who could address issues relating to diabetes, stroke and obesity, all which occurs at high rates in the Hispanic community.